DIETHYLHOMOSPERMINE IN TREATMENT OF AIDS RELATED DIARRHEA

This will be a multicenter, open-label, Phase II trial in AIDS patents with diarrhea not controlled by conventional antidiarrheal drugs (e.g., Imodium, Lomotil, Paregoric, or Sandostatin). Approximately 15 evaluable patients are expected to complete the study. An evaluable patient will be one who has either completed the entire course of therapy or one who has discontinued therapy due to adverse events. All patients receiving one dose of study drug will be evaluable for safety. Pharmacokinetic studies will be conducted in a minimum of two patients at each dose level.